Dual-mentored training for collaborative molecular biophysics

ABSTRACT:
Advances in molecular biophysics often occur when tools, techniques, and ideas from the
physical sciences are joined to biological research questions to create new insights and
opportunities, revealing microscopic design principles within biology. BPHYS is an independent
graduate training program at The University of Chicago founded on a training model in which an
interdisciplinary bridge between the physical sciences and the life sciences is built within each
student. The hallmark of the program is that our students are co-mentored by two faculty with
complementary research interests and receive a Ph.D. degree from both the Physical Sciences
Division and Biological Sciences Division. By making our students full members of both mentors'
laboratory groups at the outset, trainees learn to identify and bridge intellectual gaps between
disciplines. This allows students to overcome cultural barriers between fields and identify
opportunities for innovation. Our students greatly value this experience and intellectual
independence, and we attract daring, creative, and driven students. BPHYS trainees receive
training in both biological and physical sciences through a combination of lab-based courses,
didactic courses alongside students in traditional disciplinary programs, and program activities.
Intense interdisciplinary didactic and practical training is implemented by the trainee through
research on an innovative, student-designed, dual-mentored thesis project, which is investigated
using both physical and biological approaches. The trainee is a full member of both mentors'
laboratories and becomes adept at communicating across disciplinary boundaries. Program
mentors actively recruit (and compete for) our BPHYS students because they forge new and
lasting collaborations between groups. Due to this demand, we have increased the number of
students who matriculate into the Program to ~10 per year with no drop in quality with further
growth supported by our applicant pool and trainer funding profiles. Accordingly, this application
requests 10 trainee slots to support 5 students in the Program in their first and second years.

Public health relevance
The Graduate Program in Biophysical Sciences provides an innovative training model designed for bold students with strong physical science backgrounds to prepare them for careers in biomedical research. Using a distinctive dual-mentor approach, that involves pairing faculty from across a wide range of disciplines, the Program trains individuals to develop and apply new approaches in molecular biophysics to a variety of biomedical topics. The funds will also contribute to public health by supporting innovative coursework and community-building activities to improve how science is taught, first locally, and then as a national model of training for the national Biomedical Research Workforce.